Deciphering the functional role of recurrent PPP2R1A mutations on endometrial metastasis

Project Summary: Uterine serous carcinomas (USC), uterine carcinosarcomas (UCS), and leiomyosarcomas
represent the most aggressive subtypes of uterine cancer and account for a disproportionate number of uterine
cancer related deaths in the United States. The lethality of these high-grade uterine cancers is largely due to the
propensity of these cancers to disseminate and metastasize, leaving patients with a lack of effective treatment
options. Despite this, the molecular drivers of the metastatic potential of these disease subtypes remain
incompletely understood.
Previous work by our group and others have identified a recurrent mutational hotspot within the gene
encoding for the A scaffolding subunit of the protein phosphatase 2A (PP2A), PPP2R1A. These mutations,
P179R and S256F, occur exclusively within these high-grade subtypes of uterine cancer and are not found in
any other cancer type. Protein phosphatase 2A (PP2A), is a family of serine/threonine phosphatases, where the
active heterotrimeric form is comprised of the catalytic (C) subunit, the scaffolding (A) subunit, and a substrate
directing regulatory (B) subunit. In aggregate, PP2A is considered a tumor suppressor protein, but certain
heterotrimers have tumor promoting roles. We have shown that these mutations contribute to uterine cancer
tumorigenesis by modulating PP2A function in a manner that impairs the formation of tumor suppressive
heterotrimers, while leaving tumor promoting heterotrimeric complexes intact.
My preliminary data show that the PP2A P179R and S256F mutations enhance tumor initiating capacity,
and the ability to form 3D tumor spheres in vitro. Importantly, uterine cancer cells expressing these mutations
also form intraperitoneal nodules at an increased rate in vivo, suggesting that these mutations may enhance the
establishment of new tumor formation in the peritoneal cavity. Conditioned media from the mutant expressing
uterine cancer cells promoted tumor sphere formation of WT expressing uterine cancer cell growth, indicating
that the mutant cells may create a more permissive tumor microenvironment for tumor formation. Preliminary
data suggests that the mutant cells have increased -catenin phosphorylation and WNT ligand expression.
The working hypothesis of this proposal is that the recurrent mutants, P179R and S256F, enhance uterine
cancer metastasis through increased WNT signaling and secretion of WNT ligands. To test this hypothesis, we
will develop PP2A A knock-in xenograft models to determine how these recurrent mutants contribute to
enhanced metastasis in vivo (Specific Aim 1). Second, mechanistic studies will explore the secreted factors from
the mutant uterine cancer cells, exploring WNT ligands, coupled with secretome analysis. These studies will also
explore the link between loss of PP2A and WNT mediated EMT (Specific Aim 2). This proposal aims to decipher
the functional role of recurrent PP2A A𝛼 mutations on uterine cancer metastasis, which may identify a new
therapeutic target(s) of high-grade uterine cancers.

Public health relevance
Project Narrative: Uterine serous carcinomas (USC) are the most aggressive subtype of uterine cancers, yet the molecular drivers of disease spread remains incompletely understood. Previous work by our group and others have identified a recurrent mutational hotspot within the gene encoding for the scaffolding subunit of the protein phosphatase 2A (PP2A), PPP2R1A, that occur almost exclusively within the USC subtype of uterine cancer. These hotspot mutations may contribute to uterine tumorigenesis by inactivating tumor suppressive PP2A function by specifically altering holoenzyme biogenesis thereby inducing dysregulation upon WNT mediated EMT while enhancing tumorigenicity in a manner that promotes USC disease progression.